MECHANISM OF LATENCY OF HERPES SIMPLEX VIRUS

The overall goals of the program are to identify the viral and cellular factors involved in the establishment and reactivation of latent herpes simplex virus type 1 (HSV-1) infections using a mouse model.